NAPS2 Polysomnogram Core

ABSTRACT: NAPS2 POLYSOMNOGRAM (PSG) CORE
Rapid eye movement (REM) sleep behavior disorder (RBD) is characterized by dream enactment behavior,
and its neurophysiologic signature during polysomnography (PSG) is REM sleep without atonia (RSWA). RBD
usually represents a prodromal synucleinopathy, and increasing evidence suggests RSWA may serve as a
biomarker of synucleinopathy-related pathology: RSWA increases over time, predicts phenoconversion to overt
synucleinopathy, and correlates with clinical measures of synuclein pathology. However, due to lack of data
from prospective, multi-center studies, there are no established RSWA values that can be used as a
biomarker. The North American Prodromal Synucleinopathy (NAPS) Consortium for RBD was
established in 2018 to enable multicenter research in RBD with the long-term goal of promoting development
of neuroprotective clinical trials in RBD. We successfully collected retrospective PSG data from across 10
NAPS Sites. These preliminary data demonstrate feasibility of analyzing RSWA and other neurophysiologic
signals acquired during PSG across multiple sites and platforms. In NAPS Stage 2, or NAPS2, we will build on
our current large cohort of participants with RBD, and will collect research-grade PSG data from >300 RBD
participants twice, two years apart, and once from matched Control participants. The NAPS2 PSG Core will
oversee collection, analysis, and distribution of PSG data, with the overall goal of developing RSWA as a
biomarker for synucleinopathies for application in future clinical trials. The NAPS2 PSG Core will standardize
and harmonize PSG data collection across NAPS2 Sites. The PSG Core will quantify REM sleep without
atonia (RSWA) using a variety of methods, and determine the degree of within-individual progression in RSWA
over time. The PSG Core will provide key RSWA metrics to the NAPS2 Project for assessment of RSWA as a
biomarker to predict phenoconversion and track progression of synuclein-related pathology. All PSG data will
be shared publicly through the NIH-sponsored National Sleep Research Resource (NSRR), a national
repository of sleep-based electrophysiologic data. We will coordinate with the NAPS2 Data Management and
Statistical (DMS) Core to develop signal processing and novel machine learning methods for application to
electroencephalography and other neurophysiological signals recorded during PSG. The PSG Core will
explore the feasibility and reliability of alternative, non-laboratory methods for home-based PSG. The NAPS2
PSG Core will enable development of RSWA as a biomarker for prodromal synucleinopathies, promote
research with PSG-derived neurophysiologic signals, and advance technological improvements in PSG data
collection and analysis.